REGULATION OF CUTANEOUS ACCESSORY CELL ACTIVITY IN HEALTH AND DISEASE

The major focus of this laboratory has been to determine how ultraviolet radiation (UV) modulates the epidermal immune system. Low doses of UV-B administered to epidermal cells (EC) in vitro completely inhibited the ability of freshly-isolated Langerhans cells (fLC) to support the mitogenic response of T cells to anti-CD3 monoclonal antibodies (mAb). Exposure of fLC to low doses of UV-B in vitro prevented LC-T cell interactions and upregulation of ICAM-1 expression by fLC. Anti-ICAM-1 mAb inhibited the proliferative response of T cells to anti-CD3 mAb supported by fLC, confirming that the ICAM-l/LFA 1 interaction is critical in this system. LC that had been cultured for 24-72 h (cLC) were functionally resistant to UV-B and expressed increased levels of ICAM-1. Because cLC express several important adhesion molecules, the functional resistance of cLC to UV-B may not result from increased ICAM-1 expression alone. cLC were functionally resistant to UV-B even though UV-B was cytotoxic to cLC. This apparent paradox was resolved when it was discovered that anti-CD3 mAb-induced T cell activation became irreversible within several hours after culture initiation, before UV-B-- induced cytotoxicity became manifest. fLC caused T cells to become activated at a substantially slower rate. The enhanced accessory cell activity of cLC relative to fLC may be attributable to the fact that cLC express significant levels of several important adhesion molecules. UV-C and psoralen + UV-A had similar inhibitory effects on fLC function and ICAM-1 expression but markedly decreased LC survival in vitro. Re-examination of the effects of UV-B on LC survival revealed that although similar numbers of LC were recovered from cultures of irradiated and unirradiated EC 24 h after culture initiation, progressively fewer LC were recovered from cultures of irradiated EC at 48 and 72 h. These results indicate that low dose UV-B is lethal to LC in vitro and presumably also in vivo.